Understanding recovery from alcohol use disorder: Longitudinal observation of two voluntary temporary abstinence periods

PROJECT SUMMARY/ABSTRACT
Alcohol use disorder (AUD) in the U.S. is a significant public health concern. NIAAA recently proposed an
operational definition of recovery from AUD to advance research in this area, including: 1) remission from
DSM-5 AUD, 2) cessation from heavy drinking, and 3) improvements in biopsychosocial functioning and quality
of life. Knowledge gained from studying recovery as operationally defined by NIAAA using novel
methodological and theoretical approaches has great potential to inform clinical practice and improve patient
care for those suffering from AUD. Most people who recover from AUD never receive treatment, and yet very
little is known about the process of “natural” recovery in the absence of intervention. Voluntary temporary
abstinence campaigns, such as “Dry January” and “Sober October,” are month-long periods of abstinence from
alcohol that are increasing in popularity. As self-initiated change attempts for a defined period, these
campaigns provide a unique means for studying natural AUD recovery. Longitudinal observational studies of
voluntary temporary abstinence campaigns can be used to test theoretically informed predictors of recovery
during and after participation in the campaign. The proposed study will test two disparate theories, self-
determination theory and behavioral economic theory, both of which are novel theories of mechanisms
underlying AUD recovery. Self-determination theory explains behavior change based on internalization of
motivation, whereas behavioral economic theory explains behavior change based on benefits and costs of
competing behaviors. Testing both theories will provide critically important information about how individuals
may initiate (or not) and maintain (or not) self-directed changes in behavior during and following intended
participation in a voluntary temporary abstinence campaign. Our objective in this proposal is to leverage two
voluntary temporary abstinence campaigns to comprehensively investigate the tenets of self-determination
theory and behavioral economic theory to better understand AUD recovery. We will recruit sex-balanced and
racially/ethnically diverse online samples who meet criteria for past-year AUD, engaged in past-month
hazardous drinking, and intend to participate in either Dry January (n = 125) or Sober October (n =125).
Participants will complete a baseline assessment prior to participation in voluntary temporary abstinence and
follow-up assessments 3, 6, and 12 months after. This innovative design will allow us to examine natural AUD
recovery, as defined by NIAAA, in the context of voluntary temporary abstinence campaigns (Aim 1), and to
test the processes of recovery described by self-determination theory (Aim 2) and behavioral economic theory
(Aim 3). Exploratory analyses will ascertain differences in theoretical predictions and test sex and racial/ethnic
differences for Aims 2 and 3. Each aspect of the research design and associated training goals were chosen
deliberately to enhance the candidate’s training and facilitate the transition to independent alcohol researcher.

Public health relevance
PROJECT NARRATIVE This early career development grant includes training in alcohol use disorder recovery research, advanced quantitative methods, and professional development by a strong mentoring team to help the principal investigator transition to an independent investigator in the alcohol field. The proposed research examines recovery from alcohol use disorder as defined by NIAAA from the perspectives of self-determination theory and behavioral economics by leveraging two periods of voluntary temporary abstinence. Training and research activities are carefully sequenced to maximize knowledge gains.